Implementation of an HIV Status-Neutral Nurse-Led Intervention to Increase Equity in Clinical Outcomes for Male HIV Self-Testers in Tanzania

Project Summary
There is a critical need for heterosexual men in Sub-Saharan Africa (SSA) to receive HIV care, including
antiretroviral therapy (ART) and pre-exposure prophylaxis (PrEP), following an HIV self-test (HIVST).
Heterosexual men in SSA are routinely shown to be at a high risk for HIV acquisition, but test at lower rates
than women and experience inadequate linkages to HIV care following a self-test, regardless of the test
result. Tanzania’s Sauti Project was launched in 2015 by the Tanzania Ministry of Health (MoH) and included
the piloting of HIVST and community-based PrEP and ART administration for women, female sex workers,
and men who have sex with men. However, heterosexual men were not included in this study, despite their
high risk. Based on feedback from men that peer-based navigation and community-based linkage to care
services are preferrable to facility-based HIV care, the STEP+cbNIMART intervention was developed. There
are three aims to this study. Aim 1.) Tailor the STEP+cbNIMART intervention for heterosexual male self-
testers. In Aim 1, the intervention will be further tailored to men through a “theater test” and feedback from
key stakeholders and topical experts, and later utilized for training Community Based Health Service
Providers (CBHSPs) who will help deliver the intervention. Aim 2.) Test the effectiveness of the
STEP+cbNIMART intervention on ART or PrEP initiation and retention for male self-testers. We will
conduct a cRCT using a hybrid type I implementation-effectiveness study design to assess the effectiveness
of the intervention. The cRCT will include an intervention and control arm, with intervention participants
receiving nurse-led community-based ART and PrEP initiation, and control arm participants receiving the
standard of care. ART and PrEP adherence will be measured through a baseline survey and subsequent
follow-ups of participants in both arms. Aim 3.) Evaluate the facilitators and barriers of implementing the
intervention to refine the intervention for adoption in other settings. We will use a qualitative approach
to explore facilitators and barriers affecting nurses’ and CBHSPs’ abilities to implement the intervention and
men’s abilities to participate in the intervention and refinements that are needed to make the intervention as
successful as possible.

Public health relevance
Narrative This study explores strategies to promote linkages to HIV care following an HIV self-test (HIVST) for Tanzanian heterosexual men who are shown to test less frequently than women and are less likely seek follow-up care following a self-test. Similar studies have shown that community-based care, including the provision of PrEP and ART, can help mitigate the various barriers that heterosexual men in Sub-Saharan Africa face when seeking HIV care in a traditional facility-based setting. Exploring novel service-delivery settings for HIV care in Tanzania is critically important in the fight against HIV/AIDS in Sub-Saharan Africa, where there are an estimated 28.5 million people living with the disease.